Dynamic Tracer Kinetic Model to Detect Preclinical Diabetic Retinopathy (DR)

Project Summary
Diabetic retinopathy (DR) is one of the most common complications associated with diabetes. Detection of
clinical DR signs can take several years from the onset of diabetes; hence, the long preclinical phase should
provide a window to apply interventions that can slow or prevent progression to clinical endpoint (mild to
severe visual impairment). In fact, early detection and treatment of DR can prevent more than 90% of vision
loss. However, the current unmet clinical challenge is finding an appropriate tool or technology to detect
preclinical signs (biomarkers) of DR. Since the retinal vessels are early and prevalent targets of diabetic
damage, sensitive identifiers of structural and functional blood vessel changes hold great potential as
biomarkers. Recent advances in retinal imaging technology have allowed a better visualization of vessel
characteristics. Adaptive Optics Scanning Laser Ophthalmoscopy (AOSLO) and OCT angiography (OCTA)
studies recently suggested that there may be a transitional vascular remodeling during the preclinical phase in
diabetic patients. Though the main benefit of these technologies is the non-invasive nature of data acquisition,
there are limitations (e.g., long scan times, limited field-of-view, motion artifacts and need for an expert
operator) that prevent these technologies to be effective preclinical detection tools to be used in a clinical
setting. Therefore, there is a great need for enhanced detection sensitivity and quantitative means to analyze
the early preclinical vasculature changes that can be readily translated into clinical practice. To address this
critical unmet clinical need, we have developed a novel dynamic tracer kinetic model to measure quantitatively
vascular permeability and blood flow changes based on fluorescein video-angiography (FVA). The approach is
immediately translatable to FVA data collected in patients as demonstrated by our preliminary data. In this
proposal, we will demonstrate that our dynamic tracer kinetic model can detect preclinical DR with a higher
sensitivity and specificity than other retinal imaging modalities such as OCTA and AOSLO. Specific Aim 1 will
optimize/validate the retinal vascular permeability and blood flow measurements against gold standard
techniques of permeability (Evans-blue) and blood flow (microspheres). Specific Aim 2 will demonstrate that
longitudinal preclinical changes in the retinal vascular permeability and blood flow detected by our model will
occur before clinical retinopathy in diabetic rodent model. Specific Aim 3 will characterize longitudinal changes
in retinal vascular permeability and blood flow in both normal subjects and diabetic patients. Specific Aim 4 will
demonstrate higher sensitivity of preclinical DR detection by the dynamic tracer kinetic model over optical
coherence tomography angiography (OCTA) and adaptive optics scanning laser ophthalmoscopy (AOSLO) in
diabetic patients without clinical retinopathy (DMnoDR).

Public health relevance
Project Narrative Detection of clinical diabetic retinopathy (DR) can take several years from the onset of diabetes; hence, the long preclinical phase should provide a window to apply interventions that can slow or prevent progression to clinical endpoint (mild to severe visual impairment). Since the retinal vessels are early and prevalent targets of diabetic damage, sensitive identifiers of blood vessel changes hold great potential as biomarkers. Using a novel dynamic tracer kinetic model to quantitatively measure retinal vascular permeability and blood flow changes based on the fluorescein video-angiography imaging modality, the goal of this study is to demonstrate that the proposed dynamic tracer kinetic model can detect preclinical DR with a higher sensitivity and specificity than other retinal imaging modalities.